Delta Opioid Receptor Regulation of Parvalbumin Interneuron Transmission and Oxycodone-Related Behavior

Project Summary/Abstract
Opioid use disorder (OUD) is a chronic and relapsing brain disorder that is characterized by an inability
to control drug use and an intense withdrawal syndrome upon cessation. In addition to flu-like somatic symptoms,
opioid withdrawal is plagued by motivational and affective disturbances that are powerful drivers of relapse.
While Mu opioid receptor (MOR)-based therapies alleviate somatic discomfort and attenuate craving in OUD,
these treatments are less effective at addressing long-lasting psychological symptoms that maintain drug use.
The delta opioid receptor (DOR) system has been consistently linked to hedonic deficits in rodent models of
affective and reward behavior, supporting a role for dysregulated DOR signaling in these symptoms of OUD.
The prefrontal cortex (PFC) is heavily implicated in OUD, and a substantial preclinical literature has linked PFC
function with affective and motivational behavior. The PFC expresses a rich endogenous opioid system that is
strongly localized to GABAergic interneurons (INs). Parvalbumin (PV) INs, a key subpopulation involved in
regulating PFC circuitry and affective behavior, express high levels of MOR and DOR and exhibit opioid-
mediated plasticity in several brain structures. My preliminary data shows a striking dichotomy in PFC PV-IN
opioid sensitivity, demonstrating that optically-evoked PV-IN transmission is strongly suppressed by DOR
activation but not MOR. Furthermore, I’ve shown that oxycodone dependence increases the efficacy of DOR
agonists for suppressing spontaneous inhibitory transmission, suggesting that repeated opioid use initiates DOR-
induced adaptations to PFC PV-IN transmission. This proposal will test the hypothesis that opioid
dependence induces aberrant DOR signaling in PFC PV-INs to mediate opioid-related behaviors in
abstinence. Aim 1.1 and Aim 1.2 of this study use whole-cell patch-clamp electrophysiology, cell type-specific
optogenetics, and selective pharmacology to determine how opioid dependence alters PV-IN intrinsic and
synaptic physiology and opioid receptor regulation of PV-IN transmission. Aim 1.3 uses immunohistochemistry
to measure changes to DOR expression in PV-INs following dependence. Aim 2 uses Cre-inducible RNA
interference in genetically engineered PV-Cre mice to reduce DOR signaling in PFC PV-INs and test the role of
PV-IN DOR in a behavioral battery assessing affective and motivational phenotypes during withdrawal. These
Specific Aims will improve our understanding of cell type-specific DOR regulation of PFC function and provide
insight into how DOR-mediated changes in inhibitory transmission impact opioid-related behaviors following
dependence. I will bring my skills in electrophysiology and slice optogenetics to proficiency and expand my
technical repertoire to include key molecular tools such as RNA interference for powerful causal interventions,
building a strong skillset for a successful career as an independent investigator.

Public health relevance
Project Narrative Opioid use disorder (OUD) is plagued by a severe withdrawal syndrome and high rates of relapse, yet current treatment options do not adequately address complex motivational and affective symptoms that persist during abstinence and drive return to drug use. Inhibitory neurons in the prefrontal cortex (PFC) are critical regulators of adaptive behavior and express a rich endogenous opioid system. This proposal aims to investigate Delta opioid receptor modulation of PFC parvalbumin interneuron transmission as a mechanism underlying motivational and affective disturbances following opioid dependence, with the goal of advancing our understanding of cellular substrates that may be targeted to alleviate symptoms of OUD.